Neurobiological impact of acute digital media abstinence among drug using college students

PROJECT SUMMARY
Addictive drug use is highly prevalent among college-aged young adults and is linked to the development of substance use
disorders and other negative health outcomes later in life. Thus, understanding factors driving use is a critical public health
concern. While prior work has linked use to psycho-social factors, increased reliance on technological devices (e.g., mobile
phones, computers, gaming consoles), has introduced new risk-factors that cannot be ignored. As digital media delivers a
consistent stream of rewarding stimuli, heavy use has the potential to dysregulate neurobiological, reward processing
systems implicated in drug use, and result in withdrawal symptoms when prevented. Digital withdrawal symptoms may
intensify digital media craving, and craving for other rewards (e.g., drugs), in turn, leading to an increased risk for addictive
digital media and drug use. Identifying symptoms of maladaptive technology use that may predispose young adults to
escalating drug use is critical. The main objective of the proposed project is to characterize individual differences in
neurocognitive digital withdrawal symptoms and drug craving, following a period of digital media abstinence, and assess
associations with digital and drug use behaviors. Brain function, and withdrawal symptomology among drug using young
adults will be examined before and after a period of digital media abstinence in which participants will surrender their
mobile phone over-night and agree to not engage in any screen-time. Specifically, alterations in reinforcement processing
brain function and responsivity to drug and technology cues, following acute digital abstinence, will be characterized (Aim
1). Drug craving and digital withdrawal symptoms (physiological, affective, cognitive) linked to acute digital media
abstinence will be examined (Aim2). Finally, relations between individual differences in substance and digital media use
history, observed digital withdrawal symptoms, and altered brain function will be examined (Aim3). The proposed aims
will expand the PI’s existing experience in addiction neuroscience by allowing her to study comorbid risk for addictive
digital and substance use and gain new training in, peripheral physiology measurement, high-resolution neuroimaging, and
subcortical segmentation techniques.

Public health relevance
PROJECT NARRATIVE In a world where digital media use is becoming increasingly ubiquitous in everyday life, understanding how symptomology of use can impact drug use trajectories will have critical implications for how technology is employed in education, the workspace, clinical practice, and public health. Research findings will elucidate mechanisms driving compulsive digital media use, help identify individuals at risk for substance addictions, and be an initial step toward informing interventions.